Training Program in Basic Cancer Research

Project Summary
The overarching goal of this longstanding “Training Program in Basic Cancer Research” is to provide the
fundamental skills necessary for our trainees to succeed in outstanding careers in biomedical cancer
research. Toward that goal we provide them with superior training in the conduct of cutting edge
research, combined with a deep appreciation of the clinical challenges that doctors and patients face. To
achieve this goal, we have created a unique Training program, now entering its 45th year, entitled the
Training Program in Basic Cancer Research (TP-BCR). Support is requested for five postdoctoral
fellows, and three predoctoral fellows from the University of Pennsylvania Perelman School of Medicine,
program in Biomedical Graduate Studies. Located at the heart of the University of Pennsylvania campus,
Wistar offers a superb research environment, recently rated “Exceptional” at the most recent CCSG
renewal in 2018. We have crafted a training program that combines unique sub-programs entitled “Bench
to Bedside Training” and a “Science Entrepreneurs” program, thus offering our trainees exposure to
clinicians and clinical problems in cancer research, unique insight into the business of science and
intellectual property, and a robust curriculum that includes workshops in teaching, writing, and grant
preparation. Our 26 faculty mentors tackle diverse questions in cancer, most have long-standing
successful training records, and all are well-funded, with an average of $890,000/year/mentor (DC). Our
current trainee pool consists of 79 trainees, which includes 24 predoctoral trainees (13 TGE) and 55
postdoctoral trainees (20 TGE). There is an average of four TGE applicants for each proffered slot, thus
allowing us to place the most highly qualified trainees in this program. All slots have been continuously
filled for the entire funding period, and our trainees continue to be highly productive, with 4.7 manuscripts
and 2 first author manuscripts per trainee averaged in the past three cycles, and 98% of our trainees
continuing in research-related or research-intensive careers. Taken together, this long-standing
program, which is the only T32 centered at The Wistar Institute, will provide the fundamental skills
necessary for our trainees to flourish in successful independent careers in cancer research.

Public health relevance
Project Narrative Training in the successful completion of cutting edge biomedical cancer research, combined with engendering a deep appreciation for clinical aspects of cancer, are necessary to train the future leaders in cancer research in the United States.